Intraoperative Pulsed Field Ablation and Lesion Assessment System

Over 6 million Americans suffer from atrial fibrillation (AF), which negatively impacts their quality of life
and is associated with high morbidity and mortality. Pulsed Electric Field Ablation (PFA) has emerged as a
promising; non-thermal, tissue-specific ablation modality for treatment of AF. During PFA, trains of ultrashort
(µs duration) high voltage (~2KV) electric pulses are delivered to the myocardium via single or multi-electrode
catheters resulting in lesion formation by induced electric fields (e-fields).
Intraoperatively, efficacy of PFA is assessed by diminution of local electrograms (iEGMs), which is
unreliable and can be confounded by myocardial stunning and edema formation. Currently, there are no
methods to intraoperatively assess PFA procedures, assess and confirm durable lesion formation.
An intraoperative PFA-LAS, which can assess procedure parameters, assess and confirm durable lesion
formation, will enable effectively deliver contiguous durable transmural lesions; significantly improving the
safety and efficacy of PFA procedures.
During this Phase 1 SBIR Project, we propose to develop a novel intraoperative Cardiac PFA Lesion
Assessment System (PFA-LAS) using “High Frequency Dielectric Sensing” (HFDS) technology developed in
our lab. HFDS technology involves redesigning the ablation electrodes of the PFA catheter as “miniature
antennae”; and intraoperatively measuring their High Frequency Reflection Impedance Electrical Properties
(HFEPs) at MHz-GHz frequencies. This enables simultaneously assess dielectric properties of the volume of
tissue undergoing ablation in contact with electrode, and deliver the high voltage PFA pulses with the same
electrodes; hence intraoperatively assess procedure parameters and confirm durable lesion formation. The
system fits in an interventional EP lab, with no changes to procedural workflow.
We will design, prototype and test in bench and animals, a first generation PFA-LAS, and definitively
demonstrate its feasibility to intraoperatively monitor procedure parameters, assess and confirm durable
lesion formation.

Public health relevance
Atrial fibrillation (AF) is a significant cause of morbidity and mortality, Pulsed Electric Field Ablation (PFA) is an emerging, highly promising; non-thermal, tissue-specific ablation modality for treatment of AF. Despite promising early clinical results, effects of procedure parameters, i.e. electrode-tissue proximity/contact, tissue type and pulse parameters on lesion formation (extent of ablation, depth and durability), edema formation, microbubble formation, etc., are largely unknown. We are developing a novel intraoperative Cardiac PFA Lesion Assessment System (PFA-LAS) which can assess procedure parameters; i.e. assess and confirm electrode tissue contact or proximity, assess and confirm lesion formation, detect/predict microbubble formation, characterize tissue type i.e. ablated, non-ablated tissue, edema, fat; will enable tailor pulse parameters to effectively deliver contiguous durable transmural lesions at reduced voltages, eliminate/reduce microbubble formation; significantly, improving the safety and efficacy of PFA procedures.